Metabolic Regulators of Tumor Growth and Progression

Project Summary/Abstract
Metabolic reprogramming is a hallmark of malignancy and a source of therapeutic targets. Progress in
translating reprogrammed activities into new therapies is limited by the fact that the vast majority of knowledge
in tumor metabolism is derived from studies in cultured cells with unknown relevance to disease biology. We
developed methods to assess metabolic flux directly in tumors from human subjects and mice, thereby
eliminating artifacts of culture. Our approach integrates multi-parametric imaging of the tumor with intra-
operative infusions of isotope labeled nutrients like 13C-glucose. We use information from pre-surgical imaging
to guide tissue sampling, so that we can assess the effects of relevant biological features (glucose uptake,
perfusion, tissue density) on tumor metabolism. After surgery, we perform a fragment-by-fragment analysis of
tumor and adjacent lung to measure fluxes and examine their relationship to histology, genetics and gene
expression. Our published work in human non-small cell lung cancer (NSCLC) demonstrated that a) contrary to
long-held expectations, these tumors oxidize glucose in excess compared to adjacent lung; b) tumors oxidize
other fuels in addition glucose, and regional fuel choice is predicted by pre-surgical imaging; and c) extensive
metabolic heterogeneity exists among human lung tumors and even within distinct regions of the same tumor.
As far as we know, our multidisciplinary approach integrating clinical imaging with metabolic flux analysis,
quantitative histopathology and molecular features is unique. Here we propose to expand our program in
human NSCLC metabolism to address emerging, pressing questions over the next several years. We are
establishing novel computational methods to better report altered fluxes throughout the complex metabolic
networks of human NSCLC. We are establishing a series of NSCLC xenografts from patients recruited to the
study, providing us with a biological test bed for hypotheses stimulated by observations made in the clinical
studies. In patients and mice, we will examine the evolution of metabolic phenotypes during cancer
progression, including by sampling metabolic flux before and after conventional and targeted therapies. We
have identified a number of candidate fuels and are now infusing patients with a series of 13C and 15N-labeled
nutrients to test which ones are consumed by tumors and how their metabolism is regulated in vivo. Finally, we
are establishing methods to disentangle the metabolic contributions of distinct cell types comprising the tumor
microenvironment in patients and mice. We believe that understanding metabolic crosstalk between cancer
and stromal cells in the intact tumor microenvironment is one of the most daunting technical challenges in the
field, but also the best opportunity to make fundamentally new discoveries. Altogether, these efforts will
generate a unique view of NSCLC metabolism with an unprecedented level of detail, biological accuracy and
relevance to human disease. They have the potential to establish new paradigms in metabolic regulation and
tumor heterogeneity and to predict which patients will respond to metabolic therapies.

Public health relevance
Project Narrative Lung cancer is the leading cause of cancer-related deaths in the U.S. and worldwide, and with dismal 5-year survival rates, improved therapies are sorely needed. Although tumor metabolism is a potential source of therapeutic targets, our current understanding of tumor metabolism is largely extrapolated from cultured cell lines with little relevance to human cancer. We developed novel methods to analyze metabolic flux directly in live human lung tumors and other thoracic malignancies, and are now using them to understand metabolic regulation in human cancer and to identify metabolic liabilities in malignant tissue.